Bringing Coherent Fetal Brain Volumes and Automated Metrics to the Radiology Workflow

PROJECT SUMMARY/ABSTRACT
Interpretation of fetal brain MRI continues to be a challenge due to fetal motion even though single-shot
techniques such as T2 weighted Half Fourier Single-shot Turbo spin-Echo (HASTE) acquisitions are used.
Unpredictable fetal movement causes artifacts and images acquired in oblique orientations. As a result, the
radiologist must interpret multiple stacks of imperfect HASTE images in varying oblique orientations, visually
interrogating up to 1,000 independent 2D images. Additionally, multiple linear measurements are used to assess
brain development. This approach is time-consuming and mentally taxing. Ironically, methods to create coherent
fetal brain volumes have existed for over a decade in the research world but none have transitioned into clinical
workflows due to long reconstruction times, the need for specialized hardware, and no infrastructure to deposit
the reconstructed volumes/biometrics into the picture archiving and communication system (PACS) for a
radiologist’s review. We will leverage the latest deep-learning strategies to perform rapid, robust, and accurate
fetal brain reconstructions and automatically generate fetal brain biometrics. We will build on the unique open-
source Children’s Hospital Research Integration System (ChRIS) to integrate results into the clinical workflow.
In Aim 1 we will develop fast methods for reconstructing coherent 3D fetal brain volumes from a collection of
clinically acquired 2D HASTE slice stacks, providing accurate automated metrics to support clinical
interpretation. Our deliverable is an algorithm that i) successfully performs fetal brain reconstructions in >95% of
cases in under 2 min and ii) provides important brain biometrics within 1 standard deviation of expert human
measures. In Aim 2 we will integrate fetal brain reconstructions and derived metrics into the clinical workflow
using ChRIS, within 5 min of study completion. In Aim 3 we will assess the impact of coherent fetal brain volumes
and automated metrics on radiological interpretation. We hypothesize that expert fetal brain interpretations will
be faster, more sensitive, specific, and concordant in the detection of abnormalities when viewing reconstructed
volumes and using automated metrics compared to viewing 2D HASTE stacks as acquired. Ground truth will be
provided by neonatal brain MRIs and the cohort will be enriched with cases where neonatal MRIs discovered
findings missed on fetal MRIs. The deliverable is a rigorous quantitative evaluation of the impact of coherent
volume reconstruction and automatic brain biometrics on the efficacy of radiological interpretation of fetal MRI.
If successful, this project will enable radiologists to interpret fetal brain MRIs as one volume instead of numerous
stacks of images in varying obliquities, saving time, and increasing accuracy. The automated metrics will further
enrich the information available to radiologists without requiring additional physician time. The ChRIS
infrastructure is freely available on GitHub and will support the next phase of dissemination of this and other
innovations to interested institutions for integration into their clinical workflows.

Public health relevance
References 1. Gholipour A, Estroff JA, Warfield SK. Robust super-resolution volume reconstruction from slice acquisitions: application to fetal brain MRI. IEEE Trans Med Imaging. 2010 Oct;29(10):1739–1758. PMCID: PMC3694441 2. Kuklisova-Murgasova M, Quaghebeur G, Rutherford MA, Hajnal JV, Schnabel JA. Reconstruction of fetal brain MRI with intensity matching and complete outlier removal. Med Image Anal. 2012 Dec;16(8):1550– 1564. PMCID: PMC4067058 3. Kainz B, Steinberger M, Wein W, Kuklisova-Murgasova M, Malamateniou C, Keraudren K, Torsney-Weir T, Rutherford M, Aljabar P, Hajnal JV, Rueckert D. Fast Volume Reconstruction From Motion Corrupted Stacks of 2D Slices. IEEE Trans Med Imaging. 2015 Sep;34(9):1901–1913. PMCID: PMC7115883 4. Hou B, Khanal B, Alansary A, McDonagh S, Davidson A, Rutherford M, Hajnal JV, Rueckert D, Glocker B, Kainz B. 3-D Reconstruction in Canonical Co-Ordinate Space From Arbitrarily Oriented 2-D Images. IEEE Trans Med Imaging. 2018 Aug;37(8):1737–1750. PMCID: PMC6077949 5. Ebner M, Wang G, Li W, Aertsen M, Patel PA, Aughwane R, Melbourne A, Doel T, Dymarkowski S, De Coppi P, David AL, Deprest J, Ourselin S, Vercauteren T. An automated framework for localization, segmentation and super-resolution reconstruction of fetal brain MRI. Neuroimage. 2020 Feb 1;206:116324. PMCID: PMC7103783 6. Lawrence GR, Marin GA, Naron SE. Simulation of a hospital picture archiving and control system (PACS). Proceedings of the 17th conference on Winter simulation. New York, NY, USA: Association for Computing Machinery; 1985. p. 543–550. 7. Strickland NH. PACS (picture archiving and communication systems): filmless radiology. Arch Dis Child. 2000 Jul;83(1):82–86. PMCID: PMC1718393 8. Xu J, Moyer D, Gagoski B, Iglesias JE, Grant PE, Golland P, Adalsteinsson E. NeSVoR: Implicit Neural Representation for Slice-to-Volume Reconstruction in MRI. IEEE Trans Med Imaging. 2023 Jun;42(6):1707–1719. PMCID: PMC10287191 9. Sean I. Young, Yaël Balbastre, Bruce Fischl, Polina Golland, Juan Eugenio Iglesias. Fully Convolutional Slice-to-Volume Reconstruction for Single-Stack MRI. IEEE Conference on Computer Vision and Pattern Recognition (CVPR), To Appear. 2024; 10. Pienaar R, Rannou N, Bernal J, Hahn D, Grant PE. ChRIS- A web-based neuroimaging and informatics system for collecting, organizing, processing, visualizing and sharing of medical data. Proceedings of the Annual International Conference of the IEEE Engineering in Medicine and Biology Society, EMBS. 2015;2015-Noember:206–209. 11. ChRIS Project [Internet]. [cited 2024 Mar 30]. Available from: ChRIS Project Website [Internet] 12. Pienaar R, Turk A, Bernal-Rusiel J, Rannou N, Haehn D, Grant PE, Krieger O. CHIPS ? A service for collecting, organizing, processing, and sharing medical image data in the cloud. Lect Notes Comput Sci. 2017;10494 LNCS:29–35.